Novel Small Molecule for Improved Dental Implant Osseointegration

PROJECT SUMMARY/ABSTRACT
Oral implants are widely accepted in dental medicine as a reconstructive treatment option for replacement of
missing teeth because of congenital tooth agenesis, periodontal diseases, or injury. Although the survival rate of
dental implants over a 10-year observation has been reported to be higher than 90% in totally edentulous jaws,
dental implants do fail in some patients due to a variety of bone density problems such as osteoporosis. Thus, a
major clinical challenge for dental implant therapy is improving and accelerating the mechanical anchorage of
the titanium implants into the jawbone to facilitate earlier functional loading. While various modifications of
implant surfaces have helped osseointegration of implants, a bone anabolic agent would increase the
predictability of a positive response for many of the bone density problems seen especially in older patients with
partial or complete edentulism. Cayman Chemical Company, Inc. had discovered and patented a series of EP4
receptor agonists designed, synthesized, and screened for target potency and selectivity, cell activity, and
metabolic and physicochemical properties amenable to the rapid systemic clearance desirable for local
administration. The lead compound of the series, KMN-159, was tested during Phase I of the project and
demonstrated its in vitro osteogenic differentiation capacity as well as its in vivo bone regeneration potential in
rat critical defect models of non-union fracture and calvarial repair. Moreover, we demonstrated that KMN-159
does not induce ectopic bone formation in contrast to the standard of care rhBMP-2. During Phase II of the
project we will evaluate the effects of KMN-159-collagen hydrogel combination as an accelerant of dental implant
osseointegration in 2D and 3D in vitro systems (Aim 1a) and in vivo in a rat experimental alveolar ridge bone
defect model (Aim1b). The most efficacious formulation dose of KMN-159 will be employed in Aim 2 to
demonstrate improved biomechanical strength of the implant. Finally, a Demo Batch of KMN-159 prepared under
GMP conditions and formulated in Helistat absorbable collagen sponges will be used to test efficacy and safety
in a GLP rabbit implant model accepted by the FDA. All the in vivo studies were designed to consider sex as a
biological variable. In sum, Cayman’s goal is to offer dentists a novel, effective, safe, economical, and easy-to-
use small molecule drug (KMN-159)-device combination that will increase the rate of dental implant
osseointegration as well as the strength of the bone-implant interface. This stable, prepackaged, ready-to-use,
flexible and easily-fitted osseointegration accelerant would augment the bone’s natural repair process and could
thus facilitate earlier implant loading and decrease the number of implant failures as compared to those receiving
implants alone.

Public health relevance
PROJECT NARRATIVE Cayman Chemical Company, Inc. will develop the active pharmaceutical ingredient (API) of a drug-device combination that accelerates and improves the mechanical anchorage of dental titanium implants into the jawbone (implant osseointegration). The aim is to address two major challenges for dental implant therapy, especially in patients with low bone density conditions: (a) facilitation of earlier functional loading and (b) decrease the number of both primary and secondary implant failures.